LIFE CYCLE EVENTS, PRODUCTIVITY, AND SCIENTIFIC IMPACT

Project #4 - Life Cycle Events, Productivity, and Scientific Impact The notion that intellectual productivity is typically high at younger ages but tapers off at later (but not necessarily late) ones is pervasive. One way in which scientific productivity may be impacted by aging is through changing constraints on scientific mobility that might allow researchers to better locate in environments that are more complementary to their changing skill set. Moreover, the production of science is distinct from its enduring impact, which may also be influenced by life cycle events. In this project, we employ modern developments in the economic study of innovation alongside novel econometric methods in order to examine the impact of life cycle events for an elite set of life scientists. Preliminary analysis reveals a large dip in moves when children enter high school followed by a significant climb after the youngest has graduated. Using data on this relationship, we will examine the impacts of moving on the publishing, funding, and patenting activity of elite scientists. Publication keywords and the breadth of journal citations will be used to examine whether moves (and the resulting change in colleagues) lead to changes in the direction of the elite scientist's research. Our analysis of enduring scientific impact will focus on the relationship between scientist death and the evolution of knowledge within scientific fields, with a particular focus on individual and scientific factors that shape this relationship. Can the untimely death of a scientist alter the trajectory of nascent fields or hasten the decline of mature ones? Can trainees, coauthors, and non-coauthor idea peers keep the flame alive and build upon a scientist's legacy, or is such a legacy mostly determined by characteristics of the scientist (e.g. his/her age, gender, etc.)? In the immortal words of Max Planck, does